Novel mechanisms underlying the impact of prenatal stress on neurodevelopment

Please See Research Strategy K08 Extension Document

Public health relevance
Please See Research Strategy K08 Extension Document